BMT in Solid Tumors

SUMMARY: Allogeneic blood or marrow transplantation (alloBMT) remains the only curative treatment for many
patients with malignant and non-malignant disorders. The primary challenges limiting the success and scope of
alloBMT have included: barriers to donor availability, non-relapse mortality (NRM), acute and chronic graft-
versus-host disease (GVHD) and relapse of underlying malignancy. Through the implementation of post-
transplantation cyclophosphamide (PTCy), translational research initiatives completed at the Johns Hopkins
Kimmel Cancer Center have successfully overcome nearly all of these challenges. The administration of PTCy
ensures that nearly every patient in need of a BMT will have a suitably matched, related or unrelated, donor.
Moreover, when administered following reduced intensity conditioning (RIC) regimens PTCy allows safe,
haploidentical (haplo) BMT to be conducted in patients up to a least age 75. Significant reductions in non-relapse
mortality (NRM) and chronic GVHD have underscored the risk of relapse as the major challenge facing our
patients with malignant conditions. Hence novel strategies to anti-tumor effects post-BMT are desperately
needed. Recent breakthroughs in cancer biology and the analysis of anti-tumor immunity conclusively
demonstrate that the human immune system plays an active role in the surveillance and treatment of cancer.
Patients with cancers that are not responding to chemotherapy or immunotherapy have an immune system that
is either exhausted or lifeless. AlloBMT provides a patient with a healthy and functional immune system that
when augmented may be capable of responding more productively to immunogenic tumor antigens. Indeed,
while donor-derived, tumor responses are known to contribute to disease control after BMT, they are associated
with deleterious GVHD. We postulate optimal graft-versus-tumor (GVT) activity needs to be tumor specific /
selective. Such activity would be enhanced by the establishment of tolerance to hematopoietic cell antigens (limit
GVHD) while harnessing (and augmenting) the response of donor-derived T cells targeting tumor neoantigens
(optimize GVL activity). To this end, the central hypothesis of this project is that the efficacy of alloBMT can be
improved by developing methods to target donor T cells against antigens selectively or uniquely expressed by
tumor tissue. Our PTCy platform is uniquely suited to exploit this scenario, which underscores the innovation of
this proposal: to boldly (and safely) broaden the scope of RIC haploBMT as an effective immunotherapy platform
for patients with high-risk, poorly responsive solid tumors including sarcomas (Aim 1), castration-resistant
prostate cancer (Aim 2) and HPV+ squamous cell cancers of the head and neck (Aim 3) who have no other
chance for cure. If successful, the impact of this work will be extremely high; the principle of biasing the donor T
cell repertoire toward tumor-specific antigens will open the door for optimizing the role of BMT to treat all human
malignancies.

Public health relevance
NARRATIVE: Allogeneic blood or marrow transplantation (BMT) remains the only curative treatment for a wide variety of high risk malignancies. The reduced intensity conditioning (RIC), HLA-haploidenticial donor (haplo) BMT with post-transplant cyclophosphamide (PTCy) platform pioneered at Johns Hopkins has successfully overcome traditional barriers of donor availability, non-relapse mortality and acute and chronic graft-versus-host disease, underscoring the risk of relapse as the major challenge facing our patients. This proposal will take advantage of the unique opportunity afforded by RIC haploBMT and PTCy to safely replace an exhausted immune system with one from a healthy donor as a stage to optimize graft-versus-tumor effects and boldly broaden the scope of this therapy to improve outcomes for patients with high-risk, poorly responsive, solid tumors.